Administrative Core

GENETICALLY-ENGINEERED PIG ORGAN TRANSPLANTATION IN BABOONS:
IMMUNOLOGICAL AND FUNCTIONAL STUDIES
CORE D: ADMINISTRATIVE CORE (Core Lead: David K.C. Cooper)
CORE SUMMARY/ABSTRACT
This request for funding includes 3 Projects relating to genetically-engineered pig kidney,
liver, and heart transplantation in baboons. The 3 Projects will be supported by 4 Cores that will
(A) provide the advanced GE pigs, (B) perform all of the immunological assays, (C) carry out all
of the histopathology examinations, and (D) provide administrative support.
The principal goal of Administrative Core D is to provide an organizational structure to
facilitate the success of the proposed Projects, and to coordinate scientific approaches and
logistics between Projects 1-3 and Cores A, B, and C. The interactions between the Projects
and Cores are essential to the success of the proposal as a whole. Collaboration and
coordination between the participants in this proposal will receive the highest priority during the
5-year period of funding.